Multiplex Proteomic Analysis for Next-Generation Newborn Screening of Wilson Disease, Cystinosis, and Primary Immunodeficiencies

Project Summary
Newborn screening for Cystinosis, Wilson disease (WD) and primary immunodeficiencies (PIDD) is critical,
because these disorders are devastating and fatal despite the existence of validated treatments. Unfortunately,
most patients with these disorders are diagnosed after developing significant complications because of a lack
of cost-effective screening methods. Patients treated before the onset of these negative sequalae have
significantly improved outcomes. Many congenital disorders are caused by mutations that result in absent or
diminished levels of proteins; thus, protein biomarkers have enormous potential in the diagnosis/screening of
congenital disorders. As proof-of-concept, we have demonstrated that liquid chromatography combined with
tandem mass spectrometry analysis of signature peptides can identify patients lacking specific protein markers
of three life-threatening PIDD, cystinosis and WD. We believe that novel targeted proteomic analyses can be
utilized as rapid, multiplexed, inexpensive approaches to screen for a broad variety of treatable congenital
disorders. Our ultimate goal is to develop targeted proteomic methods into high-throughput screens that fit
readily into established newborn screening workflows and guidelines. Our methods involve direct quantification
of extremely low abundance proteins using immuno-affinity-based enrichment combined with liquid
chromatography-tandem mass spectrometry (LC-MS/MS) applied to dried blood spots on newborn screening
cards. The objective of the current application is to drastically reduce the timer-per-sample for this proteomic
analysis so that it can be used for population-based screening. We have previously demonstrated the ability to
multiplex targets for the screening of numerous congenital disorders in a single patient in a single run. Our
central hypothesis is that a novel peptide tagging procedure can be applied to the proteomic workflow for the
multiplexing for multiple patients so that it is appropriate for NBS. Our specific aims are: (1): Development of
novel peptide tags and specific elution of peptides from monoclonal antibodies in order to reduce the
NBS run-time per sample. We will develop the use of a novel set of peptide tags so that several newborns
can be analyzed in the same mass spectrometry run in order to multiplex patient samples and bring method
runtimes to a target value of < 2 min per newborn. A second component of this proteomic method optimization
is the use of specific elution of target peptides from monoclonal antibodies after enrichment to further reduce
sample complexity and runtime. (2): Performance testing, optimization and validation in normal control
samples. The main metric that we will examine is the within-newborn reproducibility. The second metric is to
gauge the level of interference from non-target peptides across a panel of newborns. (3): Multi-dimensional
multiplex validation in blinded sets of various patient dried blood spot samples. (4): Pilot study to
estimate the rate of false positives. We will test the fully optimized multiplex proteomic method on dried
blood spots from 10,000 random newborns obtained from the Washington State NBS laboratory.

Public health relevance
Narrative Cystinosis, Wilson’s disease (WD) and Primary Immunodeficiencies (PIDD) are life-threatening inherited disorders that can be effectively treated if diagnosed early but, when left untreated, results in significant negative consequences including kidney failure, liver cirrhosis, brain damage and fulminant sepsis. It is unfortunate that there are currently no cost-effective screening methods available for early detection of these conditions, and definitive diagnosis is often not made for many years. This study is to develop targeted proteomic methods into high-throughput screens that fit readily into established newborn screening workflows and guidelines and ultimately provide the opportunity for pre-emptive treatment through newborn screening.